The Impact of Cigarillo Warnings on Purchasing and Smoking Behaviors Among Young Adult Cigarillo Users

Project Summary
Cigarillo use remains a public health concern, particularly among vulnerable populations. Young adults,
including those who are Black or African American, have the highest rates of cigarillo use. Cigarillo smoking
has many negative health effects, is associated with using other tobacco products, such as cigarettes, and
cigarillo smoke contains many toxic chemicals. Additionally, some young adults believe cigarillos to be less
harmful and less addictive than cigarettes, encouraging uptake and continued use. Significant knowledge gaps
exist in our understanding of how to effectively communicate the risks of cigarillo smoking , but one effective
strategy is through warning labels. Cigarillos are under the regulatory authority of the Food and Drug
Administration (FDA), and the FDA has mandated the implementation of six text-only warnings for cigarillos.
This R01 application will address gaps in the literature about the effectiveness of cigarillo warnings by
extending our previous research where we developed pictorial warnings for cigarillos. The specific aims of the
proposed study are to: (1) Examine the impact of a pictorial cigarillo warning policy among young adult cigarillo
smokers’ purchasing behaviors using a behavioral economics framework; and (2) examine the impact of
repeated exposure to pictorial versus cigarillo warnings on cigarillo smoking intentions and behaviors. Our
study focuses on young adult and Black/African American frequent cigarillo users ages 21-34 because they
have the highest rates of cigarillo use. We will first develop an online shopping task using the Experimental
Tobacco Marketplace and examine the impact of different cigarillo warning manipulations (pictorial, FDA text-
only, Surgeon General text-only) on cigarillo purchasing, cigarillo demand, and substitution of other tobacco
products. We will then recruit another sample of young adult and Black/African American frequent cigarillo
users to participate in a 6-week randomized control trial where they will be exposed to cigarillo warnings
weekly to examine the impact of the warnings on cigarillo smoking intentions and behaviors. The goal of this
research is to increase the effectiveness of warning labels to discourage cigarillo use among young adults,
including those who are Black or African American. The results of this timely project could inform the FDA’s
rulemaking for cigarillo warnings, thereby reducing tobacco-related morbidity and mortality.

Public health relevance
Project Narrative Cigarillo smoking rates among young adults in the U.S. are a public health concern. Despite significant health effects associated with cigarillo smoking, many young adults believe cigarillos to be safer and less addictive than cigarettes, contributing to tobacco-related morbidity and mortality. This project will address gaps in how to effectively communicate the risks of cigarillo smoking to young adults to inform regulatory decision -making for cigarillo warnings.